Preclinical validation of AVGN7 for treating obesity and type 2 diabetes mellitus.

PROJECT SUMMARY. Obesity is the most challenging non-infectious health care issue of our time. Since
1980, its prevalence has increased dramatically and as a result, so has the prevalence of many associated
disorders including type 2 diabetes mellitus (T2DM). These diseases together cost the healthcare industry more
than any other disease and despite notable advances in drug development, the burden of care is expected to
continue rising. Thus, novel approaches capable of significantly reducing adiposity and restoring insulin sensi-
tivity could revolutionize the treatment of obesity and T2DM while substantially reducing healthcare costs. Our
objective is to validate the use of AVGN7 (rAAV6:SMAD7), a gene therapeutic for enhancing skeletal muscle
mass and function, for treating obesity/T2DM. We hypothesize that AVGN7 will significantly enhance lean body
mass while decreasing fat mass and restoring insulin sensitivity. This is based on high profile preclinical studies
demonstrating AVGN7 to attenuate myostatin/ActRIIb signaling and, thereby, increasing muscle protein synthe-
sis, muscle mass, muscle strength as well as exercise and cardiac capacity. Attenuating this pathway with
genetic models is well known to prevent de novo synthesis of triglycerides and to improve insulin sensitivity.
Myostatin/ActRIIb pharmacological inhibitors have similar effects, although to date some have produced serious
off-target effects compromising their development while the projected treatment costs prohibit others from being
used to treat a chronic condition like obesity/T2DM. By contrast, AVGN7 was specifically designed to avoid
these off-target effects, to have superior activity and to be a long-term solution for chronic conditions. Our mile-
stones are to validate the use of AVGN7 in (i) restoring lean body mass and insulin sensitivity in obese mice fed
a high fat diet and (ii) preventing development of obesity/T2DM in long-term studies. The proposed approach is
truly innovative as it utilizes a novel muscle-specific gene therapeutic to combat obesity/T2DM. In essence, it
fights fat with muscle. These studies are also highly significant as they will provide proof-of-concept data to be
used in a future IND filing that in turn, will help advance AVGN7 towards clinical trials with extremely obese
subjects, those with the highest risk for developing T2DM and other serious complications.

Public health relevance
RELEVANCE TO PUBLIC HEALTH. Obesity and type 2 diabetes mellitus are highly significant public health problems. The proposed studies will develop a novel gene therapy for reducing total adiposity, increasing lean body mass and normalizing insulin sensitivity and blood glucose levels. These studies will also advance the gene therapy towards an IND filing.